PSYCHOLOGICAL AND PHYSIOLOGICAL FACTORS RELATED TO GLYCEMIC CONTROL

Studies designed to characterize the performance of people with insulin- dependent diabetes on a complex regimen of multiple injections and frequent self-monitoring. 1. Learning of decision-making skills. 2. The use of skills once learned. 3. The effect of blood sugar.